Administrative Management

Core A: Summary
The Administrative Core (Core A) will provide administrative and fiscal management for all projects and cores
in this program and facilitate and foster collaborative communications. This core will provide program-specific
administrative support including coordinating frequent interactions between projects, organizing regular
monthly meetings of all the project and core leaders and personnel (alternating between electronic and in-
person), overseeing expenditures, and developing and organizing all scientific advisory board meetings as well
as follow up communications, including documentation of the aforementioned activities. The roles of this core
comprise two main service aims. For service Aim 1, the core will provide program-specific organizational
support. The administrative staff of this core, overseen by the Program Director, will provide the necessary
administrative support to coordinate the multiple groups in this program, including organizing regular meetings
between project investigators and regular scientific advisory group meetings that will occur during the course of
the program, beginning in year 2. The administrative core will also assure regulatory and training compliance
for this program. In service aim 2, the core will oversee program-specific financial management, including the
tracking of expenditures by all groups and subcontracts, ensuring timely submission of invoices, and enabling
productive use of funds. This administrative core will therefore serve an essential cohesive function to
coordinate all project and core investigators and activities in this program.